LEFT VENTRICULAR DYSFUNCTION (SOLVD)--PREVENTION AND TREATMENT

As of 30 November l990, 280 patients had been randomized, 156 into the prevention trial and 124 into the treatment trial. Both trials are examining the effect of ACE inhibition with Enalapril on the survival of patients with LV dysfunction or failure.